Explore furin as an antiviral target to block hepatitis B virus e antigen production

Project Summary/Abstract
Chronic infection by hepatitis B virus (HBV) is a leading cause of liver cancer worldwide, which
can be promoted by hepatitis B e antigen (HBeAg) through induction of immune tolerance. Since
HBeAg loss is a therapeutic goal, it is critically important to identify the host enzyme responsible for
its production. While the structurally related core protein (p21; 183aa) assembles into capsids to
provide the venue for genome replication, HBeAg is a secreted soluble protein. It is initially translated
as fused precore/core protein (p25; 29+183aa), with the N-terminal 19aa targeting the protein to the
secretory pathway followed by its cleavage. The resultant p22 is further cleaved at the C-terminus in
the trans-Golgi network (TGN) to generate mature HBeAg. HBeAg production in cell lines can be
blocked by a proprotein convertase (PC) inhibitor. PCs present in the TGN include furin, PACE4 and
PC7, with most PCs preferring polybasic sequence while furin capable of cleaving after RXXR
sequence. Four such motifs are present at the C-terminus of p22, with fused motifs 1 and 2
(151RRGRSPR157) and polybasic motifs 3 and 4 (RRRR). Previous mutational analysis identified
HBeAg as cleavage product of motif 1. HBV genotype A has a 2-aa insertion to separate motif 2 from
motif 1 (151RRDRGRSPR159), and we found it produced three size forms of HBeAg. Transfection
experiments in the HepG2 and Huh7 human hepatoma cell lines established the small, middle, and
large forms of HBeAg as cleavage products of motifs 1, 2, and 3 (166RRRR169), respectively. In furin-
deficient LoVo cells only the small form was produced. The objective of this R21 grant application is
to further evaluate furin as the host factor for HBeAg maturation and a potential therapeutic target.
Aim 1 will establish the consequence of furin knockout on HBeAg production from HepG2 and Huh7
cells. Parental cells and knockout clones will be transfected with HBV genomes of genotype A or non-
A genotypes, or infected with HBV particles. Aim 2 will establish the consequence of furin silencing or
PC inhibition on HBeAg production from a liver progenitor cell line and primary human hepatocytes
(PHH). shRNAs against furin will be delivered to differentiated HepaRG cells and PHH. Alternatively,
PC inhibitor dec-RVKR-cmk will be added to cell culture. The impact on HBeAg production and
genome replication will be determined following HBV infection. Considering that p22 can inhibit HBV
DNA replication by forming mixed capsids with core protein, we will also examine whether blocked
HBeAg maturation has the added benefit of inhibiting HBV DNA replication. Validating the host enzyme
for HBeAg formation and secretion should provide a concrete and non-mutable target for a novel
antiviral approach against chronic HBV infection, as potent furin/PC inhibitors have been developed.

Public health relevance
Project Narrative Hepatitis B e antigen can induce immunological tolerance to prolong hepatitis B virus infection, and preventing its production may represent an attractive novel antiviral strategy. Based on our strong preliminary study, we propose that furin is the host enzyme responsible for e antigen conversion from its precursor. A series of experiments will be performed in human liver-derived cell lines or primary culture of human liver cells to test our hypothesis.